IMMUNE MECHANISMS OF MIDDLE EAR DISEASE

This study explores the pathogenesis of otitis media with effusion and accesses the contribution of the various risk factors including infection, especially viral, allergy and immune competence.